Microglial subpopulations that contribute to resilience to Alzheimers disease

PROJECT SUMMARY/ABSTRACT
Alzheimer’s Disease (AD) is the most common form of dementia, with over 5 million individuals currently
suffering from this neurodegenerative disorder. Despite the prevalence of AD, many individuals live into their
90s without any cognitive decline. A subset of these cognitively normal individuals have the amyloid-beta
plaques and phosphorylated tau tangles associated with a pathological diagnosis of AD at post-mortem
autopsy. These individuals are considered “resilient” to AD. One of the major physiological drivers of AD is
neuroinflammation. Microglia, as the brain’s innate immune cells, are a central player in this neuroimmune
process. Different microglial subpopulations drive different disease-responsive processes including beneficial
or detrimental responses to pathology. My current work is identifying these microglial subpopulations in late-
onset AD individuals. I hypothesize that the responses of specific microglial subpopulations to pathology may
mediate the relationship between AD pathology and cognitive impairment. The goal of the proposed study is
to 1) address key gaps in our understanding of microglial subpopulation responses in resilient
individuals in both humans and mice, and 2) to develop the tools and model systems needed to
manipulate specific microglial subpopulations. I will evaluate the microglial subpopulations present in both
resilient humans and a mouse model of resilience to AD utilizing single-nucleus RNAseq datasets. I will also
develop techniques to modify gene expression in specific microglial subpopulations which has not been done
before and test them in both in vitro and in vivo model systems. This will enhance both our biological
understanding of resilience to AD, and our technical ability to manipulate microglial subpopulations.
The candidate is a Ph.D. neuroscientist with training in microglial biology, mouse models, behavioral
neuroscience, and RNAseq analysis who maintains strong connections with those who perform the clinical and
neuropathological diagnosis of AD. Dr. Prater is committed to scientific research related to understanding the
biological mechanisms underlying the cognitive impairment associated with AD pathology and the mediators of
the relationship between pathology and cognition. The proposal will capitalize on Dr. Prater’s expertise in
microglial biology and specifically microglial subpopulations, behavioral neuroscience, and single-
nucleus RNAseq analysis in individuals resilient to AD pathology while allowing her to develop skills in
viral manipulation of microglial gene expression. The knowledge, data, and experience gained from this
proposal will allow Dr. Prater to successfully compete for her first R01 focused on manipulating microglial
subpopulations to enhance resilience to AD. Dr. Prater’s goal is to identify mediators of the relationship
between AD pathology and cognitive impairment that can be modified to enhance resilience to AD, ultimately
providing therapeutic potential for those patients.

Public health relevance
PROJECT NARRATIVE Some individuals are considered “resilient” to Alzheimer’s disease (AD) - they have AD pathology upon post- mortem analysis but were cognitively normal prior to death. I hypothesize that specific subpopulations of microglia mediate the relationship between AD pathology and cognitive impairment, but the subpopulations unique to resilient individuals are unknown and the tools to manipulate microglial subpopulations are limited. The proposed experiments will generate new knowledge about the microglial subpopulations in resilient humans and mice and develop new tools to manipulate microglial subpopulations to enhance resilience to AD pathology.